HARNESSING HOST RESPONSE TO PREVENT MYELOMA

Summary
In spite of major therapeutic advances there is an unmet need to gain fundamental
insights into the pathogenesis of myeloma (MM) and develop newer approaches to
prevent clinical malignancy. Our research program will build on our prior efforts in two
areas- understanding the etio-pathogenesis of myeloma and harnessing host response
to prevent cancer. In recent studies, we have discovered that chronic activation by
lysolipids underlies the etiology of MM in nearly a third of patients. We have also
developed new humanized mouse models that span the entire spectrum of malignancy,
including precursor states. These advances set the stage for next studies to better
understand how lipid-mediated inflammation may drive the development of myeloma and
how to prevent it. Understanding these pathways may have implications for mechanisms
underlying lipid-mediated inflammation in diverse states including obesity. MM and its
precursor states are also an important model to probe basic questions about how to
harness the biology of both adaptive and innate immune system to prevent cancer.

Public health relevance
Narrative Our research program focuses on understanding how the immune cells surrounding tumors can be harnessed to prevent cancers. We have also gained fundamental insights into how lipids and inflammation can drive the development of tumors. These studies take advantage of several new tools including mouse models developed by our group.